Strategies to predict and overcome resistance to cancer immunotherapy

Immunotherapies such as PD-1 blockade have revolutionized cancer care. Yet
most patients do not experience sustained (durable) benefit from blockade of T cell
inhibitory receptors. Unfortunately, current biomarkers do not adequately predict patient
response or resistance to immunotherapy; and successful strategies to overcome
immunotherapy resistance have been lacking. Both gaps reflect our incomplete
understanding of how durable immunity carried out by T cells is achieved. Progenitor T
cells normally balance the mutually opposing demands of differentiation and self-
renewal by transmitting unequal anabolic activating signals to daughter cells. In the
setting of cancer, however, sustained T cell activation skews the normal
regenerative equilibrium of balanced differentiation and renewal towards progressive
dysfunction of differentiated cells along with progressive loss of self-renewing T cells. It
was previously presumed that PD-1 blockade acted by restoring potency to the most
dysfunctional T cells. Instead, emerging consensus has demonstrated that PD-1
blockade can only function by inducing greater division and differentiation of self-
renewing T cells, which are already in peril. This preclinical and translational application
marshals our basic discoveries concerning the signaling and cell biology of T cell
regeneration to tackle a major clinical roadblock in cancer care. Performing the aims of
this proposal will enable determination of 1) whether anti-cancer immunity and
immunotherapy impact the self-renewal of CD8+ T cells; 2) whether immunotherapy can
be improved by augmenting CD8+ T cell self-renewal; and 3) whether patient response
and resistance to immune checkpoint blockade can be predicted from the abundance of
self-renewing T cells. This proposal would address two critical unmet patient needs: a
non-invasive predictive biomarker for response and resistance to immunotherapy
across cancer types; and a novel strategy for resistance-directed treatment enabling
immunotherapy to benefit the majority, rather than the minority of patients.

Public health relevance
The discovery that there are simple ways to turn our own defense mechanisms against cancer was revolutionary, leading to unprecedented cures of some patients with advanced disease that had never been possible with surgery, radiation, and chemotherapy. Unfortunately, this miraculous treatment, called immunotherapy, does not work as often as it should, and it remains a mystery why people with the same type of cancer will have different responses to the same treatment. The experiments being supported by this project are intended to create a blood test to predict whether cancer immunotherapy will work or not and also to provide a solution for patients who are not likely to respond, by adding a second medication to their treatment, which will increase their chances of responding to immunotherapy.